Mechanisms of Pathogenesis in Giardiasis

Project Summary
Infection with Giardia intestinalis is one of the most common protozoan infections in the intestines of humans
worldwide. Recent work has identified chronic and recurrent Giardia infection as a major contributor to stunting
in children, and epithelial barrier disfunction is considered a key mechanism linking enteric infections with
malnutrition and stunting. Defects in intestinal barrier function have been observed in humans, animal models
and epithelial cell cultures infected with Giardia, but the mechanisms responsible for these defects remain
poorly described. In the first aim of this proposal we will test the role of specific host signaling pathways in
contributing to intestinal carrier disfunction using in vitro and animal models. In the second aim we will
determine if parasite proteases are virulence determinants that trigger pathology in vitro and in vivo. Blocking
these pathways could greatly reduce the pathology produced during giardiasis.

Public health relevance
Project Narrative Giardia is the most commonly diagnosed protozoan cause of diarrhea in the United States and a major contributor to diarrhea world-wide. This proposal seeks to understand how the parasite disrupts the normal structure and function of the intestinal tract and the consequences of these changes for the development of nutrient malabsorption, diarrhea and growth faltering. These studies will identify novel targets for treatment of giardiasis and may also identify pathways important in the development of other intestinal maladies such as Celiac disease, Crohn’s disease and Irritable Bowel Syndrome.